Oxygen generating bioinks for 3D printed bone implants

Abstract
Musculoskeletal tissue injuries are a leading cause of disability in the United States (US), yet
there are only a few viable options for patients suffering from bone degeneration. One of the
major challenges in this field is nonunion formation, which is the permanent failure of bone
fracture healing. Current therapies such as bone fixation or bone grafting are often ineffective,
painful, invasive, costly, and do not result in recovery of full function. To overcome this grand
challenge, much research has been dedicated to the development of engineered three-
dimensional (3D) bone tissue, which typically is composed of a biomaterial containing human
mesenchymal stem cells (hMSCs) for bone formation and endothelial cells for blood vessel
formation. Although these approaches accelerate implant anastomosis, it is inherently still
associated with a prevascular phase that causes significant amounts of starvation induced cell
death. Here, we propose an innovative solution to solve this important problem. We aim to
achieve this by developing an oxygen generating biomaterial that can be used to 3D bioprint a
vascularized bone implant for critical bone defect treatments. To this end, we set-out to explore
two of our recently developed technologies: oxygen generating biomaterials and embedded
sacrificial 3D bioprinting. To maintain cell survival during the implant’s pre-anastomosis phase,
we will develop hydrophobic micromaterials containing molecules that release oxygen upon
hydrolysis, which can be controlled via tuning the micromaterial’s hydrophobicity. These
microparticles will be combined with our 3D printable and bone forming nanoparticle
incorporated biomaterial matrix (Silicate-nanoparticles/GelMA) that is laden with human
mesenchymal stem cells to effectively create an oxygenating bone forming bioink. This bioink
will be used as a viscous medium in which a 3D vascular structure will be printed using
embedded bioprinting; a novel 3D bioprinting technique that we are pioneering. Specifically, we
will endow constructs with a 3D vascular structure of endothelial cell laden alginate bioink.
Crosslinking the oxygenating bioink using low levels of UV light will yield a fully solid 3D
construct. Upon sacrificing the internal alginate structure, an open 3D vascular network will be
instantly formed. The pre-laden endothelial cells will coat the 3D network and thus provide a
functional early vascularity that will accelerate anastomosis and thus minimize the implant’s
prevascular phase. After in depth in vitro characterization using normoxic and hypoxic cultures,
we will investigate the construct’s in vivo behavior using a subcutaneous and a critical defect
model.

Public health relevance
Narrative The goal of this proposal is to develop an oxygen generating bioink for the 3D bioprinting of vascularized cell laden bone implants of clinically relevant sizes that remain viable upon implantation. This bioink will be laden with human mesenchymal stem cells and be used as a viscous medium in which a 3D vascular structure will be printed using endothelial cell laden alginate bioink and a preprogrammed 3D printer. After in depth in vitro characterization using normoxic and hypoxic cultures, we will investigate the construct’s behavior in vivo using a subcutaneous and a critical defect model. Therefore, successful development of this innovative system is expected to significantly improve the healing of critical bone defects by preventing the otherwise inevitable starvation-induced cell death of living implants. Moreover, it represents a universal approach to 3D bioprint vascularized tissues that have the unique ability to survive, function, and mature during the pre-anastomostis phase of implanted biomaterials.